Intercellular Transfer of Mitochondria at the Nerve-Cancer Interface

Title: Intercellular Transfer of Mitochondria at the Nerve-Cancer Interface
Project Summary/Abstract
Breast cancer, particularly triple-negative breast cancer (TNBC), poses a significant global health challenge, with
metastasis being a major cause of breast cancer-related deaths. Despite advances in surgical treatment, there
remains an urgent need for effective therapeutic strategies to combat the aggressive nature of TNBC. Recent
studies have shown that cancer neurogenesis (CNG), characterized by the de novo generation of nerves within
primary tumors, is associated with aggressive disease and poor patient outcomes across various cancers,
including breast carcinomas. However, the functional role of CNG in tumor biology remains unclear, and the
characteristics of the nerve-cancer interface during tumor innervation require further investigation.
We have developed in vitro and in vivo coculture models of CNG, demonstrating its association with breast
cancer metastasis. Microscopy imaging at the neuroepithelial interface has revealed significant metabolic
reprogramming of neuronal cells exposed to breast cancer cells, followed by the intercellular transfer of
mitochondria from nerves to cancer cells. Our preliminary data suggest that these mitochondrial transfers
enhance the metabolic plasticity of recipient cancer cells, promoting their metastatic potential.
The primary objective of this research is to investigate the functional role of nerve-cancer mitochondrial transfer
in cancer metastasis, identify the key mediators involved in these transfers, and assess the impact of inhibiting
this process on cancer progression. To achieve these goals, we developed MitoTRACER, an innovative lineage-
tracing genetic strategy that enables the permanent labeling of cancer cells that have acquired mitochondria
from neurons.
In Specific Aim 1, we will use MitoTRACER to determine the precise contribution of nerve-to-cancer
mitochondrial transfer to the breast cancer metastasis cascade in vivo. In Specific Aim 2, we will evaluate how
these mitochondrial transfers contribute to the generation of cancer stem cells (CSCs) in vitro and in vivo, cancer
resistance to therapy, and identify unique characteristics of nerve-mediated CSCs that could be targeted
clinically to prevent TNBC recurrence.
This project builds on our recently published findings and preliminary data, focusing on the mechanisms
associated with CNG, intercellular communication at the nerve-cancer interface, and their impact on cancer cell
metabolism and metastasis. Successful completion of this research will elucidate how cancer cells acquire
metabolic plasticity to enhance their metastatic potential, paving the way for new therapeutic strategies against
highly innervated cancers and providing innovative tools for studying mitochondrial exchange.

Public health relevance
Project Narrative Innervation of cancer tissue plays a crucial role in aggressive disease, yet how cancer cells and neurons communicate during this process remains poorly understood. Our project investigates how infiltrating nerves transfer their mitochondria to breast cancer cells, leading to increased metabolism of cancer cells, signaling changes, and dissemination of cancer cells to distal sites. We aim to uncover the underlying mechanisms and consequences of inhibiting these transfers to aid the future development of novel approaches that inhibit cancer metastasis.